Epidemiology and Genomics of Multidrug resistant Salmonella Typhi infections in Kenya: The role of carriage in an endemic setting

PROJECT SUMMARY
Salmonellae are Enterobacteriaceae that cause a spectrum of diseases in humans and animals, including
enteric (typhoid) fever and gastroenteritis. Typhoid fever, caused primarily by Salmonella enterica serovar
Typhi (S. Typhi), results in a life-threatening systemic disease that is responsible for significant morbidity and
mortality annually worldwide. The disease is endemic in many parts of Africa, including Kenya. 1-5% of
individuals infected with S. Typhi become chronic carriers with the gallbladder (GB) as the site of persistence.
S. Typhi is a human-restricted pathogen, therefore asymptomatic carriers represent a critical reservoir for
further spread of disease. We have demonstrated that gallstones (GSs) aid in the development and
maintenance of GB carriage in a mouse model and in humans, serving as a substrate to which salmonellae
attach and form a protective biofilm. However, the epidemiology regarding the development of Salmonella
chronic carriage and spread of the disease from both acute and chronic carriers is poorly understood. In this
proposal, we intend to prospectively study a population in a typhoid fever endemic region in Kenya to better
understand: (1) genomics, antibiotic resistance and biofilm phenotypes of the S. Typhi strains causing typhoid
fever and chronic carriage, (2) the linkage of GSs to the establishment of chronic carriers, and (3) the local
epidemiology and geospatial distribution of typhoid fever in the target urban community. Modeling the data
gathered will allow a greater understanding of the strains causing acute and chronic infection and the
associated epidemiologic factors contributing to S. Typhi spread in a community. This will also help healthcare
practitioners better treat and predict the likelihood of disease transmission as well as asymptomatic carriage.

Public health relevance
Salmonella Typhi causes typhoid fever in humans. 1-5% of those with typhoid fever become asymptomatic chronic carriers primarily due to biofilm formation on gallstones. In this proposal, we will study the epidemiology of disease, genetic and phenotypic traits of the strains, and the association of the infection with gallstones of patients in Kenya where typhoid fever is prevalent. The findings will help better understand the transmission of typhoid fever and the development of chronic carriers.